Mitochondrial aconitase: Fe-S cluster biogenesis and interaction with mtDNA

DESCRIPTION (provided by applicant): Mitochondrial aconitase is highly sensitive to oxidative damage during aging. It reversibly converts citrate to isocitrate in the tricarboxylic acid (TCA) cycle. The cubane [4Fe-4S]2+ cluster of aconitase is essential for its catalytic activity, but it also renders the enzyme highly vulnerable to oxidative stress. We have discovered that isolated wild-type Saccharomyces cerevisiae mitochondria contain a nucleotide (GTP, NAD(P)H and ATP)- dependent machinery for iron-sulfur cluster (ISC) biogenesis of aconitase (Aco1p). The cluster biogenesis occurs in the mitochondrial matrix by a multi-step process requiring multiple components. In Aim I, we will biochemically dissect these steps and determine the nucleotide requirements of each. In Aims II-IV, we will study proteins that we found are directly relevant to nucleotide-dependent processes in ISC biogenesis of Aco1p. These include a GTPase (Mtg1p), a NADH kinase (Pos5p), a NADPH-requiring reductase (Arh1p), and an ATPase (Ssq1p). Mitochondria lacking any of these proteins are deficient in ISC biogenesis of Aco1p and display greatly reduced aconitase activity. However, the causal defects in these mutant mitochondria must be different since these proteins have different functions. Mtg1p is a GTPase in the mitochondrial matrix, and we will test our hypothesis that Mtg1p mediates the effects of matrix GTP on ISC biogenesis of Aco1p (Aim II). Pos5p is a NADH kinase and is required for NADPH production in the matrix. We will determine if the role of Pos5p in ISC biogenesis of Aco1p is mediated by its effects on NADPH levels in the matrix (Aim III). NADPH is likely utilized by reductase(s) such as ferredoxin reductase (Arh1p), which may provide reducing equivalents for one or more steps in cluster biogenesis, and this will be tested as part of Aim III. Ssq1p is an Hsp70 chaperone with ATPase activity in the matrix. Therefore some of the effects of ATP on ISC biogenesis of Aco1p are likely mediated by Ssq1p, and this will be explored (Aim IV). In addition to Ssq1p, yeast mitochondria contain an abundant Hsp70 (Ssc1p) that is involved in protein import. In contrast, human mitochondria contain a single Hsp70 (hSSC1), and thus it may participate in both protein import and ISC biogenesis, and we will test this possibility as part of Aim IV. Aco1p is essential for mitochondrial DNA (mtDNA) stability, and this activity is independent of its enzymatic activity in the TCA cycle. Aim V is to investigate interaction of yeast and human mitochondrial aconitases with mtDNA. We will determine if human mitochondrial aconitase, like yeast Aco1p, is also bifunctional and participates in the maintenance of mtDNA. Nucleotides and/or redox status of the matrix may play a critical role in distributing aconitase between the TCA cycle and mt-nucleoids, and we will examine these possibilities. The mechanism underlying the biogenesis of ISCs of mitochondrial aconitase in yeast is likely to be very similar to that in human. Homologs of most, if not all, yeast proteins that participate in the process also exist in human. Thus, conclusions from yeast studies proposed here will be informative to human physiology.

Public health relevance
Public Health Relevance: Mitochondrial aconitase requires a 4Fe-4S cluster for its enzymatic activity in the tricarboxylic acid (TCA) cycle and is highly sensitive to oxidative damage during aging. In yeast, aconitase is also essential for the maintenance of mitochondrial DNA, and this activity is independent of its catalytic activity in the TCA cycle. This proposal seeks to investigate the molecular mechanism of Fe-S cluster biogenesis of aconitase and its interaction with mitochondrial DNA. __SpecificAimsTextDelimiter__ Specific Aims Mitochondrial aconitase is highly sensitive to oxidative damage during aging. It reversibly converts citrate to isocitrate in the tricarboxylic acid (TCA) cycle. The cubane [4Fe-4S]2+ cluster in the active site of aconitase is essential for its catalytic activity, but it also renders the enzyme highly vulnerable to oxidative stress. Iron-sulfur cluster (ISC) biogenesis of aconitase occurs by a multi-step process requiring multiple components. However, little is known about the molecular details of these processes. In Saccharomyces cerevisiae, aconitase (Aco1p) is encoded by a single nuclear gene ACO1. We have discovered that isolated wild-type yeast mitochondria contain a nucleotide (GTP, NAD(P)H and ATP)-dependent machinery for ISC biogenesis. This machinery can insert newly formed ISCs into endogenous apo-aconitase. The five specific aims of this proposal are: Aim I. To define the roles of GTP, NAD(P)H and ATP in ISC biogenesis of aconitase (Aco1p) The requirement of each nucleotide for ISC biogenesis of aconitase in isolated wild-type mitochondria will be characterized in terms of early (persulfide formation on cysteine desulfurase), intermediate (assembly of ISCs on scaffold proteins) and late (apoprotein loading) stages of the process. Ferredoxin (2Fe-2S) will be used as another substrate to determine if different pathways are involved for the insertion of ISCs into different apoproteins. We will also determine if nucleotide-dependent in vitro insertion of ISCs into apo-Aco1p correlates with the enzymatic activity of holo-Aco1p thus formed. Aim II. To determine the role of Mtg1p in ISC biogenesis of Aco1p Our preliminary data suggest that matrix GTP hydrolysis is required for ISC biogenesis of aconitase. Mtg1p is a GTPase in the mitochondrial matrix, and we find that Δmtg1 mitochondria virtually lack Aco1p activity and cannot insert ISCs into endogenous apo-Aco1p. We will test our hypothesis that Mtg1p mediates the effects of matrix GTP on cluster biogenesis. Experiments will include importing purified Mtg1p into Δmtg1 mitochondria or adding it to lysates. Results from Aim I will identify GTP-requiring step(s), which are likely to be the site(s) of Mtg1p action. Independent parallel experiments analogous to those in Aim I will be performed with Δmtg1 mitochondria to further determine the role of Mtg1p in discrete stages (see above) of ISC biogenesis of Aco1p. Aim III. To determine the role Pos5p in ISC biogenesis of Aco1p Pos5p is a NADH kinase in the mitochondrial matrix and serves as the local source of NADPH. The Δpos5 mutant lacks Aco1p activity, and we find that ISCs are not inserted into endogenous apo-Aco1p in isolated Δpos5 mitochondria. We hypothesize that the role of Pos5p in ISC biogenesis of Aco1p is mediated by its effects on NADPH levels in the matrix. NADPH will be generated in the matrix of isolated Δpos5 mitochondria by in vitro import of purified Pos5p, and we will determine whether the defects in ISC biogenesis of Aco1p are now corrected. NADPH is likely utilized by reductase(s), which may provide reducing equivalents for one or more steps in cluster biogenesis. Our data suggest that ferredoxin reductase (Arh1p), which uses NADPH for its function, is involved in ISC biogenesis of Aco1p. The effects of NADPH on cluster biogenesis may therefore be mediated by Arh1p. We will test these possibilities using isolated pos5 and arh1 mutant mitochondria. Aim IV. To determine the role of Ssq1p in ISC biogenesis of Aco1p A) We find that ATP hydrolysis is required for ISC biogenesis of aconitase. Ssq1p is a mitochondrial Hsp70 chaperone with ATPase activity, and ssq1 mutants are deficient in cluster biogenesis. Therefore some of the effects of ATP hydrolysis on ISC biogenesis of Aco1p are likely mediated by Ssq1p. This will be explored using Ssq1p imported into isolated ssq1 mitochondria, and also by adding back purified Ssq1p to ssq1 matrix extract. Ssq1p is thought to mediate transfer of ISC intermediates from scaffold proteins to apoproteins (the "late stage" above), although this has never been experimentally demonstrated. We will directly test this possibility. B) In addition to Ssq1p, yeast mitochondria contain an abundant Hsp70 (Ssc1p) involved in protein import. In contrast, human mitochondria contain a single Hsp70 (hSSC1), and thus it may participate in both protein import and ISC biogenesis. We will determine if ssq1 phenotypic defects are rescued by in vivo expression of hSSC1, particularly at a level comparable to that of Ssq1p in wild-type mitochondria. We will also test if imported hSSC1 can restore insertion of ISCs into endogenous apo-Aco1p in isolated ssq1 mitochondria. Aim V. To investigate interaction of aconitase with mitochondrial DNA (mtDNA) Yeast Aco1p is essential for mtDNA maintenance independent of its catalytic activity in the TCA cycle. How Aco1p is distributed between TCA cycle in the soluble matrix and mt-nucleoid at the inner membrane is not known. Nucleotides and/or redox status of the mitochondrial matrix may play a critical role in this process. A) Interaction of ACO2 with mtDNA: We find that human mitochondrial aconitase (ACO2) binds DNA with sequence-specificity. We will identify regions of the mammalian mtDNA bound by ACO2 in living cells. B) Bifunctionality of aconitase: We will determine if human ACO2, like yeast Aco1p, is also bifunctional and participates in the maintenance of mtDNA. C) Effects of nucleotides and ISC integrity on aconitase-mtDNA interaction: Using isolated mitochondria, we will determine whether the addition or depletion of nucleotides affects the distribution of aconitase between the soluble matrix fraction and mt-nucleoids at the inner membrane. We will also investigate if aconitase with or without its ISCs interacts differently with mtDNA or synthetic oligonucleotides.